Administration

Principal Investigator/Program Director (Last, First, Middle): Schneiderman, Neil Introduction to Core A In order to remedy weaknesses identified by the review committee (e.g., need for